Mre11-Dependent DNA Damage Responses in Breast Cancer Pathogenesis

Project Summary Abstract
The Mre11-­Rad50-­Nbs1 complex is a pleiotropic sensor of DNA double strand breaks that promotes ATM
signaling, cell cycle checkpoint activation, and DNA repair. We have recently shown that Mre11 is an essential
component of the tumor suppressive DNA damage response (DDR) in a murine model of breast cancer. Mre11
pathway deficiency has also been reported in a significant fraction of human triple negative
(estrogen/progesterone receptor negative, HER2 non-­amplified) breast cancers (TNBC), which are
characterized by rampant chromosomal instability and nearly universal inactivation of the p53 pathway. In this
project, we will investigate a role for Mre11-­mediated tumor suppression in murine models of TNBC initiated by
c-­Myc overexpression, Rb1 deletion, and/or p53 deficiency. In Aim 1, we will analyze the effect of Mre11
deficiency on cell cycle checkpoint activation in response to oncogene-­induced DNA damage. Time lapse
microscopy of DNA damage and cell cycle state transitions will be performed in preneoplastic primary
mammary epithelial cells. In Aim 2, we will use single cell whole genome sequencing to quantify stochastic
chromosomal aberrations that accumulate during oncogene-­induced replication stress in primary mammary
epithelial cells. The effect of Mre11 and/or p53 deficiency on the chromosomal instability phenotype at different
stages of tumorigenesis will be analyzed. In Aim 3, we will engineer Mre11 mutations in a Rb1/p53-­deficient
murine TNBC model to measure effects on tumor latency. Gene expression and genomic scar signatures
associated with Mre11 deficient breast cancers will be determined, and compared to signatures of Brca1
deficiency. A panel of pharmacological DDR pathway inhibitors will be tested to identify targetable synthetic
lethal vulnerabilities of Mre11 deficiency. Collectively, this project will provide insight into p53-­independent
mechanisms of Mre11-­mediated tumor suppression, and identify molecular signatures and therapeutic
susceptibilities of Mre11 deficient breast cancer.

Public health relevance
Project Narrative This project will investigate how deficiency in a critical sensor of DNA double strand breaks (Mre11) promotes the development of triple negative breast cancer (estrogen/progesterone receptor negative, HER2 non- amplified). We will elucidate molecular profiles and therapeutic vulnerabilities of Mre11 deficient breast cancer. These studies may engender novel approaches to both prevent and treat triple negative breast cancer.